Molecular mechanism of neuronal control in sweat gland development

PROJECT SUMMARY
Eccrine sweat glands are the most abundant glands in human skin and are essential for thermoregulation and
water balance. Patients with severe burn injuries and congenital sweat gland deficiencies cannot properly
maintain body temperature, which can lead to heat stroke and organ failure. The recent identification of
multipotent stem cells in sweat glands presents great potential to help these people to thermoregulate efficiently
by opening the way for de novo sweat gland regeneration. Nonetheless, regeneration of fully functional sweat
glands will require better understanding of the endogenous signals that normally regulate differentiation of sweat
gland stem cells. Precise innervation and neuronal control are indispensable for sweat glad function since
neuronal signals elicit sweating, and further, as we previously discovered in our lab, these signals are critical for
sweat gland maturation. Sweat glands and neurons rely on each other for precise co-development. However,
very little is known about how neuronal inputs influence sweat gland development, especially sweat gland stem
cells. We hypothesize that neuronal signals are critical for the specification of sweat gland stem cells
during development. Using mouse sweat glands as a model, we will investigate the molecular changes in sweat
gland stem cells during development when lacking innervation, and further identify the downstream pathway
within sweat gland stem cells that mediate the effect of neurotransmitters upon stem cell maintenance. Through
combined use of mouse genetics, immunofluorescent confocal and light sheet imaging, single-cell RNA
sequencing, fluorescence-activated cell sorting, and tissue explant and cell culture systems, we plan to: 1)
investigate the effect of denervation during sweat gland development and homeostasis; 2) dissect the roles of
specific neurotransmitters in sweat ducts and sweat gland development; and 3) understand the mechanism(s)
by which calcium mediates neuronal control of sweat gland stem cell fate. Completion of our proposed studies
will provide novel insights into molecular mechanisms by which nervous system influence sweat gland
morphogenesis and cell fate determination at different developmental stages. Further, our results will provide
groundbreaking insight into how sweat glands and nerves co-develop into a functional unit, which will in turn
facilitate regenerative therapies for patients suffering from sweating deficiency.

Public health relevance
PROJECT NARRATIVE Severe burn victims and patients suffering from congenital sweat gland deficiencies are unable to properly maintain body temperature, which can lead to hyperthermia, heat stroke, brain damage, and potentially death. Restoring the capacity of these patients to thermoregulate requires the ability to regenerate skin with functional sweat glands that are precisely regulated by the nervous system. This proposal will uncover novel molecular mechanisms of neuronal control in sweat gland development, advancing our understanding of skin and sweat gland regeneration and the development of therapeutics to treat patients with sweating deficiency.